Simulation, modelling, and estimation of direct and indirect genetic architectures and intergenerational dynamics

Project Summary
Genetic association studies have become the de facto standard study design for identifying genetic variants
associated with complex traits. Thousands of such studies, enrolling tens of millions of people worldwide, have
been conducted to date. Their results have been used for myriad purposes ranging from basic science to clinical
translation and including studies of trait genetic architectures. However, recent work from our groups and others
have shown that a widely held belief about genetic association study results is frequently incorrect. Specifically,
the assumption that underlying the loci associated with the trait of interest are causal variants directly impacting
the trait. We and others have established that these associations also contain substantial contributions from
confounding factors: gene-environment correlation due to indirect genetic effects (effects of relatives’ genotypes
mediated through the environment) and population stratification, as well as correlations with other genetic
variants due to assortative mating and population structure. Here we aim to develop methods to quantify and
resolve this issue, dissecting these often-overlooked components of intergenerational dynamics when studying
trait genetic architectures.
In Specific Aim 1, we are set to develop a comprehensive simulation framework. This framework will efficiently
model realistic intergenerational dynamics on a large scale, crucial for understanding the nuances of genetic
transmission across generations. It will serve to quantify and correct the biases inherent in current methodologies
used for studying genetic architecture, providing a more accurate lens through which to view the genetic
underpinnings of traits. In Specific Aim 2, we develop a theoretical framework for understanding the joint impact
of indirect genetic effects and assortative mating. This then enables us to develop methods that separate these
statistically confounded factors that are key to explaining intergenerational transmission of traits. By leveraging
the unique properties of family data, we will be able to build an accurate picture of the different factors that
contribute to both genetic associations and to intergenerational health and social inequalities.
Central to the success of this project is our team of diverse collaborators. Comprising experts from various
geographical locations and spanning junior to senior investigators, our team brings together a wealth of
experience in this niche area. The multidisciplinary expertise of our faculty members, encompassing genetics,
computational biology, psychology, social sciences, and other relevant fields, ensures a comprehensive
approach to tackling these complex genetic issues. By addressing the intricate intergenerational dynamics and
refining the analysis of genetic architectures, we are not only enhancing the scientific understanding of genetics
but also paving the way for more precise and meaningful applications in health and medicine.

Public health relevance
Project Narrative Large-scale genetic studies of humans have identified thousands of associations between genetic variants and human traits and diseases. However, associations can arise due to confounding factors: principally gene- environment correlations due to indirect genetic effects (effects of relatives’ genotypes mediated through the environment) and population stratification, and correlations with other genetic variants due to assortative mating and population structure. Here we develop an advanced simulation software package to study the breadth of this problem as well as novel theory and methods that enable robust estimation of indirect genetic effects and the impact of assortative mating.